Microbial and Host Factors that Promote Epithelial Disruption and S. pneumoniae Transit out of the Lung

Project Summary
Streptococcus pneumoniae causes ~900,000 cases of pneumococcal pneumonia annually in the US, with a
mortality rate of 5-7%, making this disease a major health and financial burden. S. pneumoniae lung infections can
spread to the bloodstream (bacteremia) and lead to severe patient outcomes. The goal of the proposed research
is to elucidate the microbial (Aim 1) and host (Aim 2) factors that enable this bacterium to transit from the lung to
the blood, an ability that is critical for many respiratory pathogens to cause disseminated infection. An important
virulence factor during S. pneumoniae infection is pneumolysin (PLY), a pore forming toxin, which has been
implicated in the development of bacteremia. S. pneumoniae infections are also characterized by an excessive
immune response mediated primarily by white blood cells called polymorphonuclear cells (PMNs) that can cause
host damage and result in lethal infection. Our overall hypothesis is that PLY and PMN migration disrupt the lung
epithelium, promoting bacterial transit from the lung into the bloodstream.
We will investigate this hypothesis by using an in vitro transepithelial migration assay, which allows us to assess
how bacteria transit across the lung epithelium, analogous to bacterial dissemination from the lungs into the
bloodstream in vivo. This versatile system models diverse microenvironments, is easy to maintain, and integrates
seamlessly with other molecular biology and microbiology techniques. In Aim 1 we will determine how PLY disrupts
intercellular junctions of the lung epithelium and how that promotes S. pneumoniae transit out of the lungs
independent of PMNs. To assess PLY-mediated removal of intercellular junction proteins, we will infect polarized
lung epithelial monolayers with PLY-proficient (WT) or PLY-deficient isogenic bacterial strains, stain intercellular
junction proteins with fluorescent antibodies, image the monolayers by confocal microscopy, and use Image J and
Prism software to perform quantitative image and statistical analysis, respectively. In parallel, we will quantify S.
pneumoniae transit across lung epithelial monolayers to connect PLY-mediated disruptions of intercellular junctions
to changes in bacterial migration in the absence of PMNs.
In Aim 2 we will identify how PMNs disrupt intercellular junctions of the lung epithelium and how this perturbation
promotes S. pneumoniae transit out of the lungs. To evaluate PMN-mediated removal of intercellular junction
proteins, we will infect polarized lung epithelial monolayers with WT S. pneumoniae in the presence or absence of
PMNs, stain intercellular junction proteins with fluorescent antibodies, image the monolayers by confocal
microscopy, and use Image J and Prism software to perform quantitative image and statistical analysis,
respectively. In parallel with these experiments, we will measure S. pneumoniae transit across the lung epithelial
monolayers to connect PMN-mediated monolayer disruptions with changes in bacterial migration. Collectively,
these experiments will explain how microbial and host factors disrupt the lung epithelium, leading to bacterial
dissemination, a fundamental process in S. pneumoniae pathogenesis and other lung infections.

Public health relevance
Project Narrative Streptococcus pneumoniae causes ~900,000 cases of pneumococcal pneumonia annually in the US, with a mortality rate of 5-7%, making the disease both a significant health and financial burden. The goal of the proposed research is to elucidate the microbial and host factors that enable this bacterium to move out of the lungs and spread into the bloodstream, an ability critical for many respiratory infections to cause severe disease. Understanding how these microbial and host factors contribute to more severe outcomes in patients will help us design novel therapies to combat pneumonia and other lung infections.